Cancer Center Administration

The primary mission of the MUSC Hollings Cancer Center (HCC) Administrative Support Division (ASD) is to provide administrative leadership, oversight, and support for the research infrastructure and activities of HCC leaders and members. The Administrative Support Division accomplishes this by providing critical services to facilitate and enhance scientific productivity and collaboration for 130 members who are organized into three research programs, utilize HCC-supported shared resources, and benefit from HCC financial, space, and personnel resources. Administrative services include:
• Oversight, coordination, and execution of the CCSG application process and CCSG reporting;
• Oversight of research and grants administrative processes;
• Coordination of and participation in center-wide strategic planning and evaluation efforts;
• Stimulation and support of inter-, intra-programmatic, and multi-center interactions; services include targeted grant development support and consultation, meeting organization, and retreat/seminar/symposia coordination;
• Administrative oversight and management of HCC-supported shared resources, including the establishment of user fees, billing, auditing, coordination of, and participation in oversight committees and user evaluations;
• Administrative leadership and coordination of HCC strategic activities that include education and training, workforce development, and community outreach and education;
• Coordination and oversight of all center-related development/fundraising activities;
• Fiscal management and oversight of all university and the Medical University of South Carolina Foundation accounts related to the center;
• Facilities management of all assigned HCC space (i.e., assignment, utilization, maximization) and equipment;
• Coordination of faculty recruitment and retention in collaboration with other university departments;
• Human resource management of center staff;
• Coordination and documentation of center meetings;
• Management of HCC membership, including application processes and annual reviews;
• Administration of HCC intramural funding opportunities, including solicitation, receipt, award, and monitoring of pilot projects;
• Coordination of communications and public relations for all center activities.